Vision Impairment in the National Health and Aging Trends Study

PROJECT SUMMARY/ABSTRACT
At least 14 million people in the U.S. are blind or living with a vision impairment (VI), and the number
affected is projected to double by 2050 due to aging and growth of the U.S. population. The majority
of those with VI and blindness are older adults aged ≥65 years. Racial and ethnic minorities are also
disproportionately affected, in part due to social determinants of health (SDoH) like healthcare
access, economic stability, and features of the built environment. Particularly in later life, VI is thought
to be associated with a host of adverse outcomes, including dementia, admission to a long-term care
facility, and even mortality. Nonetheless, rigorous and generalizable research on how SDoH impact
vision and eye health, and how vision influences late-life outcomes has been limited due to a lack of
data that: (i) is longitudinal; (ii) is representative of the U.S. population; (iii) contains objective
assessments of visual function; and (iv) samples older adults. In the proposed project, we will
address this barrier using newly collected vision data from the NIH-funded National Health and Aging
Trends Study (NHATS), an ongoing nationally representative panel study of >7,000 adults aged ≥65
years. In 2021, NHATS began annual measurement of distance and near visual acuity and contrast
sensitivity. In Aim 1 of the proposed study, we use NHATS data to provide the first-ever estimates on
the incidence of VI and blindness at the national level, as well as national prevalence estimates
stratified by age, sex, and race and ethnicity. In Aim 2, we will evaluate the longitudinal influence of
SDoH on vision health. To do so, we will utilize individual-level indicators of SDoH from NHATS, and
neighborhood level-indicators from the NIH-funded National Neighborhood Data Archive that is linked
to NHATS. In Aim 3, we will investigate the longitudinal impact of VI and blindness on the
development of dementia, placement in long-term care, and all-cause mortality. In a sub-aim, we will
use a longitudinal mediation model to test whether the influence of SDoH on adverse late-life
outcomes is mediated by vision and eye health. To date, it has not been possible to carry out
nationally representative studies on the associations of VI with SDoH and key late-life outcomes due
to the lack of longitudinal and objectively measured visual function data in a national sample. Thus,
the proposed studies will address critical scientific gaps. This proposal is also highly responsive to the
National Eye Institute’s new 5-year Strategic Plan, including: (i) to gather current epidemiologic data;
(ii) to support research at the nexus of SDoH and the healthcare system; and (iii) to explore research
encompassing comorbidities. Epidemiological estimates will be made publicly available and all study
findings will be widely disseminated to maximize the impact of these studies on public health and
policy and to optimize vision and overall health and wellbeing for an aging U.S. population.

Public health relevance
Public Health Relevance Statement PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on providing up-to-date estimates of the number of older adults in the U.S. with vision impairment and blindness, as well as key insights on the associations between risk factors, vision impairment and blindness, and late-life outcomes like dementia, long-term care placement, and mortality. This study will use newly collected vision data from the NIH-funded National Health and Aging Trends Study (NHATS) to conduct longitudinal analyses that are nationally representative of older adults aged ≥65 in the U.S. Thus, the proposed research is relevant to the NIH’s mission to enhance health and reduce illness.